Professional Development Core: Houston Area Incubator for Kidney, Urologic and Hematologic Research Training (HAI-KUH)

The Houston Area Incubator for Kidney, Urologic, and Hematologic Research Training (HAI-KUH) addresses
key challenges related to recruitment, advancement, and retention of pre- and postdoctoral trainees and clinical
fellows in the KUH fields. Successful career transitions of trainees into independent investigators require multi-
faceted educational strategies, which include cross-cutting professional skills. The Professional Development
Core will augment research experiences with an innovative professional development program that employs
modern learning techniques and emphasizes active participation through faculty- and peer-led small group
sessions and a mentored approach to individual development plans that includes skills development and career
preparation. Through a comprehensive matrix of professional development resources that emphasize training
excellence, the Professional Development Core will address the advancement and competitiveness of HAI-KUH
trainees and improve their retention in KUH research fields in both academic and non-academic settings. Aim 1
is to develop a cohort of KUH trainees prepared to launch in their chosen direction by leveraging faculty-to-
trainee, peer, and near-peer interaction plans through interactive monthly learning sessions that cover a range
of essential cross-cutting skills, opportunities and feedback on oral presentations, professional critiques on
scientific writing, and professional development bootcamps in the areas of entrepreneurship/commercialization
and team science, as well as tailored training plans. Aim 2 is to enhance skills and trainee competitiveness
through HAI-KUH pods, individual development plans, and a HAI-KUH Professional Development Dashboard,
where the pods will function as an interactive unit to facilitate both horizontal (peer) and vertical mentoring to
ensure that trainees take advantage of all resources available to them and to support the successful transition
to independence. Aim 3 is to develop a cohort of preceptors and trainees trained in mentor and mentee best
practices, optimizing training experiences and outcomes since mentor development and training rooted in
mentoring best practices are critical for successful career transitions. This includes a strong focus on mentor
training in diversity and inclusion, as well as the recruitment, retention, and career development of trainees from
underrepresented groups in biomedical science. Refinement of strategic approaches based on recurring cycles
of evaluations will ensure that the activities are well integrated, in line with the overall vision and mission of HAI-
KUH, and complement the goals of the Networking and Training Cores. In synergizing with the large established
training programs in the Texas Medical Center, the Professional Development Core will increase trainee
competitiveness, support successful career transitions to independence, improve retention of trainees in
research careers in both academic and non-academic settings, and, ultimately, impact the KUH research target
areas as defined by the NIDDK.
0

Public health relevance
The Houston Area Incubator for Kidney, Urologic, and Hematologic Research Training (HAI-KUH) aims to develop a highly qualified workforce of dedicated research professionals to improve the health and quality of life of patients with nonmalignant kidney, urologic, and hematologic diseases. Through our robust network of KUH researchers from multiple Houston institutions and a variety of scientific backgrounds, we will collaborate to not only expand existing efforts but seize the opportunity to support a range of career paths, promote interdisciplinary research, and bring training excellence to graduate students and postdoctoral and clinical fellows to KUH mission areas.